NMR STUDIES OF AGING IN CELLS, ORGANS, AND ANIMALS

NMR spectroscopy is currently being used at the NIA to study the phosphorus metabolism of peripheral muscle in BLSA subjects and other volunteers, as well as in animals. Age-related and exercise-related effects are under investigation. Methodologic studies to further develop kinetic and spin-lattice relaxation time measurement methodology are also under active investigation.